Leveraging Nanoparticle Interactions with Host Immune Cells to Detect and Treat Cancer

Abstract
The goal of this proposal is to support Dr. Preethi Korangath, as a Laboratory Research Specialist at Dr. Robert
Ivkov’s laboratory in Johns Hopkins University. With her expertise in mouse models, molecular biology and
imaging she will facilitate successful completion of R0-1 projects in unit director’s lab. Dr. Korangath’s successful
career is evident through her publications in high impact journals and conference presentations. This Research
Specialist Award will provide protected salary support for Dr. Korangath to pursue new directions and developing
new technologies that enable early detection and treatment of cancer. Despite advances in cancer treatment
and understanding, metastasis remains the main challenge in extending cancer patients' lives. Early detection
of metastatic disease is crucial for effective treatment. Developing new imaging modalities to detect
micrometastases using magnetic particle imaging (MPI) offers a non-invasive, radiation-free approach with high
sensitivity and specificity. This could revolutionize cancer diagnostics and treatment, improving patient
outcomes. However, further understanding of MPI's clinical applications is necessary. Dr. Korangath equipped
with expertise in various mouse models and imaging techniques aims to leverage MPI for early metastasis
detection and study the role of host cells in cancer progression.

Public health relevance
Narrative Early detection of cancer is key to better treatment options and longer survival. Developing new imaging modalities that outperform standard imaging techniques currently in use will help achieve this goal. With my experience and expertise in both basic and translational science, I will enable the successful development of nanoparticle-based detection of early metastasis using magnetic particle imaging in Dr. Robert Ivkov’s laboratory. This R50 Research Specialist award will support my goal of developing new techniques for the detection and treatment of cancer, as well as training the next generation of students and postdocs.